Mass Spectrometry Core Facility

The Mass Spectrometry Core Facility (MSCF) of the Center for Biomolecular Structure and Dynamics (CBSD)
at the University of Montana facilitates MS-based approaches for the characterization of proteins and small
molecules. Under the direction of Dr. Kendal Ryter, and the management of Dr. Eric Schultz, the Core makes
available well-maintained equipment and instrumentation that is not normally found within individual
laboratories, providing access and training for researchers within the University of Montana as well as other
regional research organizations. In order to meet the needs of its research community, the MSCF strives to
maintain a state-of-the-art research environment, provide consulting and staff support for MS sample
preparation and analysis, and continue to develop new services to stay at the forefront of biophysical and
biomedical research. Active outreach programs are utilized to inform the regional research community,
encourage use of the MSCF, and foster collaborations with the Core and associated faculty. Through frequent
evaluation and consultation with clients, the MSCF ensures that services provided meet or exceed the needs
of our researchers, fostering their own innovation, and providing opportunities to incorporate MS-based
approaches in future work.